RESEARCH SUPPORT SERVICES FOR DAIDS

The objective of this acquisition is to provide DAIDS with comprehensive travel and conference support to facilitate the DAIDS research efforts necessary for accomplishing its program goals.